Point of care detection of HPV in saliva

Expanded point-of-care (POC) screening and monitoring options for detection of disease biomarkers from easily
collectable specimens such as saliva are needed to reduce the incidence and mortality rates of debilitating
diseases and enhance the resilience of the medical system, and improve care. InnoTech Precision Medicine
with Massachusetts Institute of Technology is working to develop an innovative diagnostic platform that can be
used for POC screening and monitoring of disease biomarkers. In our initial proof-of-concept, we are developing
a POC test for detection of high-risk HPV in saliva. HPV is a viral infection that causes most Oropharyngeal
squamous cell carcinoma (OPSCC) cases. Recent studies have demonstrated that HPV can be detected in
saliva from patients with OPSCC. Currently, the initial screening and diagnosis of OPSCC is done at the late
symptomatic stage based on symptoms that are often mild and can mimic less serious conditions such as cold
or sore throat, delaying diagnosis and treatment. DNA tests for HPV are most often based on RT-PCR detection
of the viral genetic material from serum or saliva that is collected and sent to central laboratories. RT-PCR-based
tests rely on the amplification and detection of viral genetic material. These tests have long actionable turn-
around-time, and high cost. Thus, there are no rapid, accurate and low-cost tests for routine monitoring of high-
risk groups (i.e., young, sextually active, multiple partner) and monitoring of response to therapy and recurrence.
Thus, a POC test for non-invasive monitoring of HPV in saliva during well-being exams can have a significant
impact and save lives. Our objective is to develop a rapid, easy-to-use prototype for the detection of HPV in
saliva based on the combination of biochemical signal amplification with CRISPR-Cas 12 electrochemical
readout and our proprietary robust, accurate and low-cost gold-leaf electrodes. Utilizing our proprietary gold-leaf
electrode along with a CRISPR-Cas12 assay for sensitive and specific electrochemical detection of target nucleic
acid (NA) biomarkers, we have already demonstrated the detection of HPV 18 with plasmid DNA as well as in
patient specimen. Our overall objective for this proposal is to develop a reproducible process for processing of
saliva and develop a prototype electrochemical biosensor for the multiplex detection of HPV 16 and HPV 18
along with a reference gene to ensure accurate test results. To accomplish this goal, we will first develop a
workflow for spatial multiplexing of our gold leaf electrodes for detection of HPV16, HPV 18 and an optimal
reference gene. We will then verify this multiplexed test initially with plasmid DNA, and then with saliva
specimens. We anticipate that combining easy-to-fabricate spatially multiplexed electrodes with CRISPR-
Cas12a for the detection of a specific nucleic acid sequence will enable our Phase II development, regulatory
approval and commercialization of a point-of-need technology that can be scaled and manufactured for accurate,
easy-to-use and low-cost point-of-need testing and to reduce the burden of HPV infection and OPSCC.

Public health relevance
Narrative This NIH SBIR Phase I project will support the development of a sensitive, easy-to-use, low-cost, multiplex POC test for detection of HPV in saliva. Robust strategy for saliva processing and novel methods for specific Cas12- based readouts of multiplex HPV using proprietary gold-leaf electrodes will be developed.